The Long-Term Effects of Welfare Reform on Life Course Health

Project Summary/Abstract
There are over 11 million children living in poverty in the United States. There are also substantial racial
disparities in childhood poverty. In 2019, 8.3 percent of White children and 7.3 percent of Asian children were
living in poverty, while 20.9 percent of Hispanic children and 26.4 percent of Black children were living in
poverty. Adults who experienced childhood poverty are more likely to have worse health outcomes compared
to adults who did not experience childhood poverty, including 50% lower odds of reporting good general health
and 71% higher odds of having heart disease. Childhood poverty’s impact on subsequent adult health is well-
documented, but few studies examine the long-term effect of economic policies on this relationship. Welfare
reform represented a major shift in the 1990s in how the United States distributed cash benefits to Americans
needing financial support. About 25 years have passed since states began to implement changes to welfare,
shifting from a less restrictive and more generous form of welfare distribution through the Aid to Families with
Dependent Children (AFDC) program, to a more punitive and less generous form, through the Temporary
Assistance to Needy Families (TANF) program. At its height in 1994, AFDC served 9.6 million children, while
TANF served only 1.6 million children in 2020, suggesting a large decrease in welfare benefits distribution. Due
to the close link between financial resources and health, economic policies serve as potential interventions to
promote population health and decrease socioeconomic (SES) health disparities. Studies on welfare reform
have found important implications of this policy change on short-term health outcomes, including reduced
access to health insurance and decreased health care utilization. These findings suggest potentially negative
long-term health outcomes due to welfare reform, though research in this area is limited. Studies on long-term
effects of other safety-net policies, such as the Food Stamp Program, have found that more benefits are
associated with better long-term health. We propose to fill this gap in studies on the long-term health effects of
welfare reform with this project. First, we assess the state-level variation in the relationship between childhood
SES and self-rated health, chronic conditions, and psychological distress in adulthood to understand how state
context may lead to larger or smaller health disparities rooted in childhood SES. Based on findings from other
studies that examine state-level variation in adult health disparities, we expect to find state-level variation, and
for this variation to be driven by adults whose families were lower-SES. Second, we quantify the effect of
welfare reform on the relationship between childhood SES and self-rated health, chronic conditions, and
psychological distress in adulthood. Lastly, due to evidence of racial discrimination in welfare administration,
we estimate the extent to which the long-term health effects of welfare reform differ based on race and
ethnicity. We hypothesize that welfare reform will have negative long-term health effects for the low-SES
sample, and for those effects to be particularly detrimental for individuals who are Hispanic and/or Black.

Public health relevance
Project Narrative Childhood poverty is closely linked to poor health in adulthood, though it is unclear if economic policies buffer this relationship by providing financial resources during a critical developmental period. Welfare reform in the 1990s represented a major shift in how the United States federal government distributed cash benefits to low- income Americans, and an opportunity for researchers to assess how different approaches to welfare programming affect health along the life course. In this project, we examine self-rated health, chronic conditions, and psychological distress of adults based on their exposure to welfare programs as children to understand the potential of economic policies to mitigate the long-term negative health effects of childhood poverty.